CHARGE-RELAY CATALYSIS IN SERINE PROTEASES

Proton inventory studies, kinetic studies in mixtures of protium oxide and deuterium oxide, will be used in studies of the mechanism of action of the enzyme Alpha-chymotrypsin. A model cationic peptide surfactant which has been suggested to mimic the "charge-relay" chain of Alpha-chymotrypsin will be studied as well. The primary aims of the research relate to the so-called "charge-relay" mechanism of serine proteases. Alpha-Chymotrypsin modified by methylation at N-3 of histidine-57, a key component of the active site, will be studied in both acylation and deacylation reactions to outline the role of the "charge-relay" mechanism in catalysis by serine proteases. The origin of the large solvent isotope effects in a system where the classic charge-relay mechanism is precluded will provide mechanistic details not available from any other studies. A highly attractive "charge-relay" model system will also be mechanistically defined using the technique. In essence, the proposed research will allow us to determine whether or not previously determined proton inventories for Alpha-chymotrypsin reactions which have been interpreted in terms of a charge-relay mechanism are valid or not. Kossiakoff and Spencer (1) have concluded, based on neutron diffraction studies, that the interpretation is incorrect.